Texas A&M Center for Environmental Health Research

Overall ABSTRACT

The vision for the Texas A&M Center for Environmental Health Research (TiCER) is to nucleate research
and translational activities of faculty and trainees around the overarching theme “Enhancing Public Health by
Identifying, Understanding and Reducing Adverse Environmental Health Risks.” This vision will be achieved by
building on Texas A&M University’s ongoing investments in people and facilities and a history of state-­wide
outreach to community stakeholders, with a particular focus on underserved populations. Existing environmental
health investments at Texas A&M provide infrastructure and a diverse expertise base ready to catalyze
innovative investigations into environmental health concerns of affected communities and populations, build
multidisciplinary collaborations among Center members to elucidate mechanistic links between environmental
exposures and adverse health outcomes, and translate mechanistic data to actionable outcomes. The Center
will continue recent successes in mentoring junior faculty, recruitment of additional established faculty into
environmental health research, and fostering a multi-­disciplinary, team-­oriented intellectual environment among
a core group of 54 members representing 11 colleges at Texas A&M. The thematic areas the Center will expand
upon are: 1) Stressors to Responses;; 2) Environment and Metabolism;; 3) Individuals to Populations;; and 4)
Community, Regulation and Policy. The Center’s vision will be fulfilled through a highly integrated set of Facility
Cores. The Integrated Health Sciences Facility Core will support bi-­directional translation with a human
translational studies component, a mouse translational studies component and an in vitro translational studies
component. Three technology-­integrating, research facility cores (Data Science, Bio Science, and Chem
Science) will ensure Center member access to unparalleled instrumentation and resources of Texas A&M, a top
tier public research university with extensive outreach throughout the state of Texas. The facility cores will
enhance the capacity, breadth, collaborative nature, and impact of environmental health research. The
Administrative Core and Pilot Project Program will facilitate the Center’s function by ensuring continuation of the
highest levels of institutional support, fostering career development and promoting multidisciplinary team science
that generates knowledge in areas of community concern. The Community Engagement Core will be a critical
vehicle for implementation of a multi-­prong strategy of the Center by serving as a bi-­directional portal to connect
Center members, affected communities and other stakeholders that builds on a strong tradition of Texas A&M
in public and community service statewide with a research focus on the health and environmental concerns of
underserved populations. Overall, the Center will expand the established investigator base and expertise that
can be deployed to increase the impact of environmental health research in Texas and beyond.

Public health relevance
Overall NARRATIVE The Texas A&M Center for Environmental Health Research (TiCER) will nucleate research and translational activities of faculty and trainees around the overarching theme “Enhancing Public Health by Identifying, Understanding and Reducing Adverse Environmental Health Risks.” This vision will be achieved by building on Texas A&M University's ongoing investments in people and facilities and a history of state-wide outreach to community stakeholders, with a particular focus on underserved populations. Overall, the Center will expand the established investigator base and expertise that can be deployed to increase the impact of environmental health research in Texas and beyond.